Real-Time Detection of Staphylococcus aureus Transmission in Hospital Settings

SUMMARY
Staphylococcus aureus infections, especially methicillin-resistant strains (MRSA), lead to high morbidity and
mortality rates in hospitals. Currently, hospitals primarily rely on clinical cultures for MRSA surveillance, which
often fails to accurately detect transmission events due to their inability to assess genetic relatedness among
bacterial strains. Using whole-genome sequencing (WGS) for early outbreak recognition is crucial for
enhancing infection control measures that will reduce the morbidity, mortality, and dissemination of pathogenic
genetic variants. However, our preliminary hospital-wide WGS analysis indicates that detecting MRSA
transmission in real-time remains challenging because individuals involved in asymptomatic transmission
events are not sampled. Consequently, asymptomatic acquisitions often remain unnoticed until readmission or
subsequent screening, delaying timely intervention and effective cluster management. Timely detection of
transmission events is essential to stop the spread of MRSA and prevent outbreaks. To address the issue at
the implementation level, we propose a two-pronged approach. In Aim 1, we will integrate weekly colonization
sampling with hospital-wide genomic surveillance to analyze phylogenetic relationships among S. aureus
strains. This will help establish a method for detecting real-time transmission events in high-risk hospital wards.
Aim 2 focuses on developing predictive models that combine patient, bacterial, and contact network
characteristics linked to in-hospital transmission events. These models will synthesize demographic,
spatiotemporal, and genomic data to optimize sampling intervals and, ultimately guiding future studies of real-
time targeted interventions. We will also compare the cost-effectiveness of different sampling strategies. By
enhancing our understanding of transmission dynamics and personalized predictive modeling, this research
will shift hospitals from reactive to proactive management of S. aureus transmission clusters. The results will
also provide crucial inputs to inform the design of future randomized trials to evaluate these strategies’ effects
on morbidity, mortality, and cost. These insights are expected to have broad implications for the surveillance
and management of other hospital-acquired pathogens, ultimately contributing to better patient outcomes and
more efficient use of healthcare resources.

Public health relevance
PROJECT NARRATIVE Hospital-acquired infections from Staphylococcus aureus, especially methicillin-resistant (MRSA) strains, pose substantial health risks, leading to high morbidity and mortality rates. Our research will establish real-time genomic surveillance by optimizing the application of advanced sequencing techniques through longitudinal colonization sampling. This proactive approach will enable the development of predictive models for early detection of transmission events and shift hospital practices from reactive to proactive management of MRSA outbreaks, thereby enhancing infection-control strategies and improving the efficiency of healthcare resource utilization.